Cardiovascular Biomechanics and Imaging

Project Summary
The primary goal of our training program in “Cardiovascular Biomechanics and
Imaging” is to continue attracting, training, and graduating highly qualified, multi-
disciplinary scientists in the area of cardiovascular bioengineering at pre- and
post-doctoral levels. The program was created 15 years ago in response to: 1)
the dearth of training opportunities available at the intersection between
cardiovascular medicine and bioengineering at the University of Colorado and
indeed within the Greater Rocky Mountain region; and 2) the strong institutional
commitment to build bioengineering research and training within the University of
Colorado. We believe the first 15 years have produced outstanding outcomes,
with all pre-doctoral (except one) and post-doctoral graduates of the program in
research positions within academia or industry, and many successfully receiving
research grants and trainees of their own. Further, NHLBI T32 funding has been
important in leveraging a large amount of additional funding from the University
of Colorado, which will be used to help support our next cycle of trainees. We
believe the combination of outstanding outcomes, significant and continuing
institutional support, and growing reputation continue to make a compelling
argument to continue this program.

Public health relevance
Narrative This program aims to train the next generation of scientists to perform research and training at the interface between cardiovascular medicine and bioengineering. The program aims to provide trainees with sound engineering breadth and depth, as well as a robust understanding of clinical and biomedical research and vocabulary in the cardiovascular sciences.